The Effect of Sleep on Neural Circuit Connections

Project Summary/Abstract – NO CHANGES FROM PARENT GRANT
A fundamental question in neuroscience and human health is how do different brain states alter neuronal
connections and how are these changes carried out at the cellular and molecular levels? We propose to
address this question by examining neuronal connections through out the compact, completely described
nervous system of the transparent nematode C. elegans as its whole brain activity cycles between
wakefulness and sleep. Specifically, we propose to use our ability to modulate the C. elegans brain state to
examine how the structure and function of excitatory as well as inhibitory synapses are changed as a function
of recurrent neural activity. Further, we will identify the molecular mechanisms by which this is achieved. In
Aim 1, We will ask how the brain states affect synaptic architecture across the animal's nervous system by
testing different types of connections throughout the animals for their response to wakefulness and sleep. We
will then ask whether the number or size of connections is affected. We will also identify the molecular
regulators of the brain state-dependent synaptic changes, and visualize synaptic components in each brain
state to determine how and when synapses are altered. These studies would provide the first evidence of
broad sleep-dependent synaptic remodeling in C. elegans. In Aim 2, We will characterize the activity calcium
transients (GCaMP6/7), cGMP fluxes (WincG) and neuropeptide-driven GPCR ligand binding (D-lite adapted
reporters) of the entire brain of C. elegans as it sleeps and compare that to the wakeful animal. Using this
information we will assess the pattern of these changes and relate them to the structure of synaptic
components within the units that change most. We will attempt to understand if the synaptic changes are
dispersed brain-wide and whether these connections are responsible for stabilizing sleep dependent changes
in behavior. We will then alter the brain activity using optical manipulation of ChR, Arch, our cGMP-sponge
WincD and cell and timing specific regulation of neuropeptide processing during sleep to test the requirement
for patterned activity to direct changes in connections that we observe. In this way, we will begin to understand
how brain state effects structural changes that affect behavior. These studies would provide the first brain wide
understanding of the interplay between the activity and structure of connections in any animal. This
understanding will provide insights into novel approaches to therapies aimed at mitigating activity-driven
changes in human brain activity that promote maladaptive responses to activity such as addiction and post
traumatic stress disorder.

Public health relevance
Project Narrative – NO CHANGES FROM PARENT GRANT Insults that alter the brain's activity wreck enduring changes in the brain's structure: opioid use results in addiction and traumatic events in Post Traumatic Stress Disorder (PTSD). How the brain's activity during and after these insults alters the fundamental connections between cells in the brain is not known but we propose to utilize the power of whole brain imaging coupled with optogenetic manipulation and synapse imaging in a live, behaving animal to reveal the rules by which whole brain activity stably changes the structure of the brain itself. Understanding the interplay between structural changes and brain state and behavior will provide insights into approaches that could exploit brain activity to address addiction and possibly PTSD.